SURFACE MODIFICATION FOR SELECTIVE PROTEIN ADSORPTION

The goal of this project is to promote selective adsorption of proteins to modified surfaces. Several scenarios are proposed and are being investigated simultaneously but all involve self-assembly of molecules with thiol-terminated ligands on atomically-flat gold surfaces. Reactions are then carried out on this derivatized monolayer in order to hierarchically build two-dimensional arrays of active receptors which selectively adsorb a specific protein and thus elicit specific cell responses. Current activity is focused on a series of porphyrins, which possess an ideal size for recognition group spacing.